Pilot Project Program

Project Summary- Pilot Project Program
The Pilot Projects Program (PPP) of the Mount Sinai P30 Center on “Health and Environment Across the
LifeSpan” provides funding for “start-up” research projects targeting important environmental health science
(EHS) issues, particularly those that fit our life course theme and research groups. The PPP is supplemented
with >$100,000 of institutional funding annually which allowed us to award an average of $397,000 (direct
costs) in EHS pilot grants annually this grant cycle. Going forward, in this proposal, we will partner with three
other NIH- funded Mount Sinai P30 Centers (i.e. Cancer, Aging, and Skin Biology), City University of New
York (CUNY), and our Clinical Translational Science Aware (CTSA) to co-fund EHS-focused pilot grants (e.g.,
aging and the environment, clinical translational environmental health). These partnerships not only further
augment EHS pilot grant funding, they also build new collaborations and attract researchers with no previous
EHS research experience to our Center. PPP applications are peer-reviewed using NIH review criteria and are
prioritized if 1) they are likely to lead to a larger extramural grant, 2) if the PI is an early stage investigator
(ESI); 3) if the proposal is a multi-PI grant with a postdoctoral fellow who pledges to use the project for a K
grant application, and 4) if the proposed pilot is a Community-Based Participatory Research project (CBPR). In
the Center's first 8 years, we distributed 78 pilots totaling ~$2.4 million. In return, these pilots have led to 43
NIH grant applications, 19 of which are already funded. We have doubled our NIEHS overall funding from
2018 to today, and tripled our NIEHS funding since the Center was founded. The PPP also enhances Facility
Core usage and provides a strong vehicle for career development. Our ESI support mechanisms have been
remarkably successful, with 48 of 78 funded pilot grants awarded to ESIs. Our Center has fueled many new
cross-disciplinary pilot grant collaborations among its Members, and Pilot Project PIs have come from multiple
departments, including Genetics (Drs. Faith and Pandey), Global Health (Dr. Vreeman), Oncology (Drs.
Muhammed and Lujambio), Otolaryngology (Dr. van Gerwen), Dermatology (Dr. Chipuk), Neuroscience (Dr.
Morishita), Pediatrics (Drs. Berin, Chu, Satlin), and Nephrology (Drs. Nadkarni and Zhou) among others.
These PIs had no prior EHS research experience before receiving a P30 pilot grant. Our CBPR funding set-
aside program and prioritization efforts increased CBPR funding from 3 grants in the Center's first 4 years, to
12 CBPR grants in the last 4 years. The PPP Core created many of the supports that accelerated our
remarkable growth over the Center's first 8 years. We have clearly demonstrated our ability to leverage pilot
grants for future NIH awards and to bring new investigators into EHS. Going forward, we will increase our total
outlay in pilot funding through cross-disciplinary partnerships with other Mount Sinai P30 Centers, CUNY and
our CTSA, ensuring that our Center expands into cross-disciplinary research programs, meets pressing EHS
research needs and engages communities while bringing EHS into greater regional and national attention.